Engineering Natural Killer Cell Derived Extracellular Vesicular Nanodrug for Tumor Targeted Bioimaging and Therapy

Natural Killer (NK) cells are large granular lymphocytes that belong to the innate immune system, and their major
function is to provide host defense against microbial infections and tumors by immune surveillance of the cell
surface to find the abnormal expression of major histocompatibility complex (MHC) class I molecules and cell
stress markers. NK cells target cancer cells directly via inhibitory and activating receptors on cell surfaces and
can kill cancer cells without prior sensitization, therefore NK cells are now at the forefront of the cell-based
preclinical studies. However, their limited numbers (5–10% of peripheral blood lymphocytes) and their lower
isolation yield (~2-5% yield) hinder their use in cell-based therapy. To overcome these limitations, high-yield
cellular products such as extracellular vesicles (EVs) are of great interest because a single cell produces
thousands of EVs equipped with parent cell-specific cargos of proteins, lipids, and genetic materials, which can
be selectively taken up by neighboring or distant target cells. Within this background, we hypothesized that
precision drug delivery will be enhanced when guided by EVs derived from NK cells that naturally seek cancer.
Recently, the PI demonstrated experimental variabilities that affect EVs production and proteomic cargos using
mouse macrophage and breast cancer cell-derived EVs. These EVs are heterogeneous in size and were found
unstable for longer periods when stored at +4 to -80 °C. However, when engineered with liposomes, they are
monodispersed and exhibit a higher order of colloidal stability and enhanced tumor delivery. Engineered EVs
showed differential targeting and uptake against normal and cancerous cells, putting them in the group of potential
tumor-targeted drug delivery candidates. These outstanding findings from engineered EVs further support the
reported evidence that EVs carry functional properties from their parent cells, which are instrumental in target
recognition. For example, EVs secreted by macrophages target tumors. Lesson learned from the EVs’ biology and
our experience in liposomes, we further hypothesized that engineering EVs with liposomes will overcome their
respective shortcomings, such as size heterogeneity and instability in EVs and the lack of targeting biomarkers in
liposomes, to efficiently navigate complex biological system to deliver drugs to their targets. Aligned with this
hypothesis, we propose to engineer hybrid EVs (HEVs) generated from the engineering of NKEVs with liposomes
containing clinically used anticancer doxorubicin and near-infrared dye for image-guided downstream therapeutic
analysis. Our specific aims are: Aim 1. To engineer NKEVs with liposomes as a nanodrug HEVs and study their
physicochemical properties. Aim 2. To elucidate the biocompatibility and cellular specificity of HEVs. Aim 3. To
evaluate the biodistribution and therapeutic efficiency of HEVs. We will develop two molecularly different; MCF-7
(ER/PR positive and HER2 negative) and MDA-MB-231 (triple negative, ER/PR/HER2 negative); human breast
cancer xenografts and study biodistribution and therapeutic efficiency. The research team anticipates the results
will assist drug delivery system designs in accelerating the precision imaging and therapy of cancer.

Public health relevance
PROJECT NARRATIVE This proposal aims to engineer extracellular vesicles (EVs) with an active anticancer drug and exogenous tags for downstream in-vivo analysis of tumor therapy. Cells continuously release EVs which play a crucial role in intracellular communication with their target cells, for example, EVs released from tumors survey a metastatic site and create a particular microenvironment or niche to develop metastatic cancer, and EVs released from immune cells seek diseased cells. Therefore, delivering drugs with engineered EVs originating from natural killer cells that naturally seek cancer would help in precision cancer therapy and monitoring therapeutic response.